Biomarkers for Early Detection of Hepatitis B-Related Hepatocellular Carcinoma in Hispanics

Infection with hepatitis B virus (HBV), is the most common risk factor for the development of hepatocellular
carcinoma (HCC) worldwide. HBV infection can cause HCC before liver cirrhosis, thereby affecting younger
persons. A recent study from our South American Liver Research Network (SALRN) found that HBV-related
HCC occurs at earlier ages in Hispanics than HCC related to other liver diseases. This HBV complication is of
particular concern as HCC occurs outside of the “standard” recommended age for starting HCC screening.
Currently, individuals with HBV are advised to undergo ultrasonography of the liver every 6 months with the
goal of “visually” identifying a tumor small enough that might be amenable to curative treatment. This visual
screening approach has poor adherence due to a variety of issues, such as time commitment, and is
dependent on the ultrasound operator expertise. We hypothesize that a non-visual screening approach with
standardized immune-related blood biomarkers may be a sensible alternative approach. Our group recently
identified a series of immune markers detected in serum of patients with hepatitis that were able to predict the
future development of HCC, even when the cancer occurred two years later.
In this project, we will investigate whether the hyper-immune environment, product of the continuous presence
of the virus in the liver, could lead to further alterations in measurable immune analytes in serum so to predict
early HCC development. Using our multinational on-going networks of SALRN and ESCALON in Latin
America, we propose to cross-sectionally and prospectively evaluate peripheral immune variations in Hispanic
HBV-infected individuals as markers to predict early HCC development.
In Specific Aim 1, we will determine if novel immune signatures in the serum of persons with chronic
HBV infection and hepatocellular carcinoma show differential expression compared to controls.
We will evaluate a pre-defined panel of immune analytes via multiplex cytokine analysis comparing HBV-
infected HCC cases with controls
In Specific Aim 2, we will validate a novel immune signature in serum for identifying those who will
progress to hepatocellular carcinoma in persons with chronic HBV infection.
We will prospectively collect samples from HBV-infected Hispanics in two regions of high HBV prevalence in
South America and validate our HCC-immune signature
In Specific Aim 3, we will evaluate intrahepatic immune markers in HBV-infected livers at risk for HCC.
We will use spatial genomics intersected with HBV staining in liver biopsies from Latin America to further
understand the mechanisms behind immunomodulation of HBV-related HCC
This study will provide innovative data that will impact Hispanic persons living with chronic HBV infection, seeking
to create a new standard of care for liver cancer screening in this population.

Public health relevance
Project Narrative/Public Health Relevance Hepatocellular carcinoma (HCC) is the most frequent malignancy of the liver and infection with hepatitis B virus (HBV) is the most common risk factor for HCC. Early detection of HBV-related HCC is critical for a curative therapy to be implemented, but there are no reliable blood markers to predict early-onset HCC. We hypothesize that immune-markers in blood related to the immune reaction of the body towards HCC can be used to identify HBV-infected individuals with early HCC and we therefore propose to cross-sectionally and prospectively evaluate peripheral immune variations secondary to HCC in HBV-infected individuals as markers to predict early HCC development.